CAHFS Toxicology VetLIRN support

PROJECT SUMMARY
The objective of this proposal is to describe our laboratory's involvement in the FDA
Veterinary Laboratory Response Network (VetLIRN) and complimentary activities. The
proposal describes how we plan to provide analytical support for the analysis of animal
tissues, feeds, foods, and other matrices of concern in the event that there is a chemical
contamination incident that potentially compromises the safety of our nation's animal
food supply or the health and safety of livestock, companion animals, or people. We
propose to participate, as needed, in the development and expansion of analytical
methods designed to screen for variety of matrices for diverse and potentially harmful
chemicals, including unknown compounds, using GC/MS, LC/MS, ICP/MS, ELISA, and
other analytical methodologies. Laboratory personnel will participate in training
exercises designed to assess the ability of VetLRN to respond to surveillance,
emergency response, and recovery scenarios, participate in national and regional
meetings, and assist with the development and validation of methods for the analysis of
chemical contaminants.

Public health relevance
PROJECT NARRATIVE The primary objective of this project is to provide analytical chemistry support to the FDA-CVM VetLIRN program to assure safe and contaminant-free animal feeds and animal-derived human foods and to assist in case diagnostic, surveillance, emergency response and recovery exercises as the need arises. The Toxicology Section of CAHFS has been an active participant in VetLIRN since its inception.